Testing the Efficacy of FFC-AC-EIT in Patients with Alzheimers Disease and Related Dementias

Older adults with Alzheimer’s Disease and Related Dementias (ADRD) comprise approximately 25% of
hospitalized older adults. These individuals are at increased risk for functional decline, delirium, falls,
behavioral symptoms associated with dementia (BPSD) and longer lengths of stay. Physical activity during
hospitalization (e.g., mobility, bathing, dressing) has a positive impact on older adults including prevention of
functional decline, less pain, less delirium, less BPSD, fewer falls, shorter length of stay and decreased
unplanned hospital readmissions. Despite known benefits, physical activity is not routinely encouraged and
older hospitalized patients spend over 80% of their acute care stay in bed. Challenges to increasing physical
activity among older patients with ADRD include environment and policy issues (e.g., lack of access to areas to
walk); lack of knowledge among nurses on how to evaluate, prevent and manage delirium and BPSD;
inappropriate use of tethers; beliefs among patients, families, and nurses that bed rests helps recovery and
prevents falls; and lack of motivation/willingness of patients to get out of bed. To increase physical activity and
prevent functional decline while hospitalized we developed Function Focused Care for Acute Care (FFC-AC-
EIT) for patients with ADRD. Implementation of FFC-AC-EIT changes how care is provided by having nurses
teach, cue, and help patients with ADRD engage in physical activity during all care interactions. FFC-AC-EIT
was developed using a social ecological model, social cognitive theory and the Evidence Integration Triangle.
It involves a four-step approach that includes: (1) Environment and Policy Assessments; (2) Education; (3)
Establishing Patient Goals; and (4) Mentoring and Motivating of Staff, Patients and Families. The purpose of
this study is to test the efficacy of FFC-AC-EIT within 12 hospitals in Maryland and Pennsylvania randomized
to FFC-AC-EIT or Function Focused Care Education Only (EO) with 50 patients recruited per hospital (total
sample 600 patients). Aim 1 will focus on efficacy at the patient level based primarily on physical activity,
function, and participation in function focused care, and secondarily on delirium, BPSD, pain, falls, use of
tethers, and length of stay; and all of these outcomes (except length of stay and tethers) along with emergency
room visits, re-hospitalizations and new long term care admissions at 1, 6 and 12 months post discharge; and
at the unit level the aim is to evaluate the impact of FFC-AC-EIT on policies and environments that facilitate
function and physical activity at 6, 12 and 18 months post implementation. Hospitals randomized to FFC-AC-
EIT will be compared with those randomized to Function Focused Care Education Only (EO). Aim 2 will
evaluate the feasibility, based on treatment fidelity (delivery, receipt, enactment)136, and relative cost and cost
savings of FFC-AC-EIT versus EO. Findings will address several prioritized areas of research: a focus on
ADRD; improving physical function; and training of hospital staff and will demonstrate efficacy of an approach
to care for patients with ADRD that can be disseminated and implemented across all acute care facilities.

Public health relevance
NARRATIVE Function focused care is an approach to care in which nurses acknowledge older adults’ physical and cognitive capabilities and integrate physical activity into all care interactions. This care approach prevents the decline in function, limited physical activity, behavioral and psychological symptoms, among other adverse outcomes in hospitalized patients with Alzheimer’s Disease and Related Dementias (ADRD). Our goal in this work is to demonstrate the efficacy of a practical and effective intervention, FFC-AC-EIT, to optimize function and physical activity and prevent adverse events among hospitalized patients with ADRD.